FASEB's The Microbial Pathogenesis Conference: Mechanisms of Infectious Disease

Project Summary The 2021 FASEB Scientific Research Conference on “Molecular Pathogenesis: Mechanisms of Infectious Disease” is the 14th bi-annual meeting that uniquely brings together outstanding international scientists from multiple infectious disease disciplines to share their latest discoveries on a variety of pathogens. As seen with the latest pandemic of COVID-19, infectious diseases remain a scourge of humankind as a leading cause of death throughout the world. Whether in the developing or developed world, emerging and re-emerging diseases combine with the alarming rise in antimicrobial-resistant infections, resulting in an increased need for research on microbial pathogens and host immunity. Pathogens, including viruses, bacteria, eukaryotic parasites and fungi, have evolved similar virulence strategies as they must overcome similar host responses. During this meeting we bring together a diverse population of scientists from all these pathogen-specific communities to discuss new basic research and medicine, discover potential synergistic collaborations and novel strategies to approach microbial pathogenesis. This FASEB Research Conference on Molecular Pathogenesis is a unique, small conference (100-150 people) that brings together scientists with primary interests in virology, bacteriology, mycology, parasitology, and immunology, and is thus an essential tool to help achieve the mission of the National Institute of Allergy and Infectious Diseases in “leading research to understand, treat, and prevent infectious?diseases.” This year’s meeting is led by Chair Dr. Kim Orth, PhD Investigator/Professor, HHMI/UT Southwestern Medical Center and co- Chair Dr. Ken Campellone, PhD Associate Professor, University of Connecticut with 36 invited scientists from diverse populations. As with past meetings, the FASEB 2021 meeting is held at the conference center in Snowmass, Colorado, which allows for almost every participant to share their science either by presenting a poster (3 afternoon sessions) or a giving one of 54 talks while allowing for intensive discussion and networking. We are honored to start our meeting with a Bernard Fields Memorial Lecture given by Dr. Andrew Camilli, PhD Professor, Tufts University, a former FASEB chair and longtime participant of this meeting. This application requests support to enhance the conference through the attendance of additional underrepresented minority, female, and junior investigators.

Public health relevance
Project Narrative As evidenced by the last year with COVID-19, infectious disease remains the major source of mortality throughout the world. Challenges remain on all fronts, as pathogens evolve and adapt to environments whether they are urban, rural, underdeveloped or highly developed living quarters. The infectious agents, viruses, bacteria, fungi or parasites must face and overcome similar immune defenses present in the human host. The alarming rise of drug-resistant pathogens and inadequate treatment options make rapid progress in infectious disease research essential. To address this dire need for knowledge and tools, FASEB hosts a Scientific Research Conference on “Molecular Pathogenesis: Mechanisms of Infectious Disease” that uniquely brings together outstanding scientists from multiple infectious disease disciplines to share their latest discoveries on a variety of pathogens, thereby allowing for discovery of common threads used by the infectious agents. This meeting brings together a diverse population of international students, postdocs, industry and academic scientists to discuss infectious disease, generate unexpected collaborations and provide an open forum for the young scientists in this field to learn and network in the infectious disease community. This year marks the 14th in a long-running series of conferences originating in 1994 and will be held in July of 2021 at the conference center in Snowmass, Colorado.